Implementing and evaluating the Family Life, Activity, Sun, Health, and Eating (FLASHE) Survey, BRP (Contract HHSN261201200039I)

The Division of Cancer Control and Population Sciences (DCCPS) aims to reduce the risk, incidence, and deaths from cancer as well as enhance the quality of life for cancer survivors. The Division conducts and supports an integrated program of the highest quality genetic, epidemiologic, behavioral, social, and surveillance cancer research.